IGF::OT::IGF Core Support for NCI Tobacco Cessation and Cancer Control Resources

National Cancer Institute (NCI) has developed smoking cessation services for multiple population groups and diverse audiences. NCI needs to provide core support for the content and on-line resources to effectively reach these populations and audiences.